Mechanism of Dioxygen Reduction by Heme-Copper Oxidases

The primary objective of this research is to elucidate the mechanism of electron and proton transfer during the reduction of dioxygen to water by heme-copper oxidases. Our specific aims will focus on four problems: 1. The mechanism of the reduction of dioxygen to water by bacterial heme-copper oxidases will be studied by the CO flow-flash method. Time-resolved multichannel optical absorption spectroscopy, in conjunction with singular value decomposition (SVD) and global exponential fitting analysis, will be used to follow the kinetics of electron and proton transfer and to deduce the UV-Vis spectra of the transient intermediates. These studies should provide new insight into the mechanism of the dioxygen reduction reaction by heme-copper oxidases. 2. We will investigate the reaction of dioxygen with bovine heart and bacterial oxidases in different oxidation states using dioxygen which is produced in situ by photodissociating synthetic dioxygen carriers. We will also extend this approach to rapid dioxygen binding and activation in ribonucleotide reductase (RNR), in which the reactions occur too rapidly to be monitored by conventional stopped-flow methods. 3. The intramolecular electron transfer in the bacterial oxidases, bo3 from E. coil, aa3 from Rhodobacter sphaeroides and ba3 from Thermus thermophilus will be investigated using a photoactivatable dye, thiouredopyrene-trisulfonate (TUPS), covalently linked to single reactive cysteine residues on the oxidases. Time-resolved optical absorption spectroscopy, in conjunction with SVD and global exponential fitting, will be used to determine the spectra of the intermediates present and the rate constants of individual electron transfer steps. By varying the distance between the labeled cysteine and the initial electron acceptor and by introducing breaks into presumed electron transfer pathways by site-directed mutagenesis, detailed information regarding intramolecular electron transfer pathways in heme-copper oxidases will be obtained. 4. We propose to make chemical analogs of the active site of cytochrome oxidase, including the His-Tyr cross-linked dipeptide and the cyclic pentapeptide (His-Pro-Glu-Val-Tyr) with and without Cu-ligands incorporated. The analogs will be studied using a multispectroscopic approach, including steady-state and time-resolved UV-Vis spectroscopy, FTIR and ESR.